CD 8 T Cell Mediated Disruption of Blood Brain Tight Junction

DESCRIPTION (provided by applicant): Disruption of the Blood Brain Barrier (BBB) is common pathologic feature of numerous serious neurological diseases. Despite the enormous burden of morbidity and mortality due to these neurological diseases associated with CNS vascular permeability, the underlying molecular mechanisms of how inflammatory cells promote BBB disruption remain poorly understood. We have developed a novel murine model of CNS vascular permeability that provides a tractable approach to defining specific inflammatory mediators that disrupt the BBB in vivo using Theiler's virus infection. This murine model of BBB disruption is initiated by peptide-specific stimulation of CNS infiltrating CD8 T cells and is not mediated by TNF-a, IFN-γ, LTβR and IL- 1. However, perforin is critical for both CNS vascular permeability and preservation of BBB tight junctions. Notably, MHC-identical C57BL/6 and 129 Svlm mice differ dramatically in susceptibility to PIFS, despite having identical CD8+ T cell responses and CTL activity. The goal of this proposal is to test our underlying hypothesis that CD8 T cells utilize perforin to initiate the disruption of cerebral endothelial cell BBB tight junctions. Specific modifier genes on the C57BL/6 and 129 SvIm mouse background are also critical for this process to occur. We will determine using this model: 1.) the cellular source of perforin necessary for BBB disruption, 2.) the role of hematopoetic cells in promoting disruption of the BBB, and 3.) the chromosome location of genetic factors that govern BBB disruption. We will use conventional genetic analysis, protein biochemistry, imaging, cellular immunology assays, molecular biology and retrovirus expression to determine the inflammatory factors that mediate disruption of the BBB. Identification of powerful factors that contribute to fatal CNS vascular permeability would define targets for therapeutic modification of the BBB. Such diseases characterized by disruption of the BBB including stroke, viral hemorrhagic fevers, cerebral malaria, HIV dementia, multiple sclerosis (MS), and shock. Increased understanding of BBB permeability could also benefit chemotherapy. PUBLIC HEALTH RELEVANCE: Inflammation mediated blood brain barrier (BBB) disruption is a poorly understood, yet relatively common feature of numerous neurologic diseases. We have developed a novel murine model of CNS vascular permeability that can be utilized to define specific cellular interactions and inflammatory mediators that result in disruption of the BBB in vivo. Defining such factors is the first step towards novel therapeutic modification of BBB permeability.

Public health relevance
Project Narrative Inflammation mediated blood brain barrier (BBB) disruption is a poorly understood, yet relatively common feature of numerous neurologic diseases. We have developed a novel murine model of CNS vascular permeability that can be utilized to define specific cellular interactions and inflammatory mediators that result in disruption of the BBB in vivo. Defining such factors is the first step towards novel therapeutic modification of BBB permeability.